Joint Effects and Community-Level Characteristics in Estimating Cerebrovascular Risk Among HIV Infected and Uninfected Veterans

The overall objective of this study is to determine the efect of neighborhood-level characteristics along with individual-level joint characteristics on cerebrovascular disease (CeVD) outcomes among HIV positive and negative veterans. The proposed epidemiologic strategy, which has been underutilized in HIV and CeVD research, includes multi-level analyses that incorporate a neighborhood-level characteristic (race and ethnic segregation) along with the joint efects of individual-level characteristics (HIV treatment, mood disorders, alcohol/drug abuse/dependence) in estimating the incidence of CeVD. This will be the frst study to consider neighborhood-level along with the joint efects of individual-level characteristics in HIV and CeVD research.

Public health relevance
This proposed study will examine the excess cerebrovascular disease (Ce VD) risk associated with HIV by including population-level characteristics (neighborhood racial/ethnic segregation) and assessing individual-level joint effects. This study will also estimate risk of Ce VD across levels of racial/ethnic segregation for the neighborhoods of VA facilities, which may become useful for VA policy on prevention and clinical management. The findings of this study can help identify targets for interventions that can help improve the health of Veterans, including policies that 1) minimize inequalities in social and material resources across communities 2) target key neighborhood-level features such as availability of healthy foods or access to public transportation and healthcare, and 3) the information learned from the impact of race/ethnic segregation on Ce VD risk may help improve clinical risk stratification for all Veterans.